Discovery of Chemical Probes and Therapeutic Leads, Phase 3, Analytic Core

Project Summary
We propose a Phase III COBRE to continue and sustain our work to discover new chemical probes and lead
molecules for biological research and therapeutic discovery. The goal of the Analytical Chemistry Core
(Analytical Core) is to provide the UD campus with the central infrastructure for the study and characterization
of molecular structure, interactions and reactivity. The Analytical Core provides support for core facilities in mass
spectrometry (MS), proteomics, Nuclear Magnetic Resonance (NMR) spectroscopy and kinetic analysis. With
COBRE support over the past decade, the core has grown into one of the most impactful units on the UD campus,
providing 589 researchers in 80 research groups with access to 25 major instruments. The facilities created
through this core are unique to the State of Delaware and are impacting research in academia and industry
throughout the region. In Phase III, we propose a management structure for the Analytical Core that will support
growth and sustainability. We describe a plan to grow the biological mass spectrometry user base during Phase
III by supporting core instruments, providing hands-on training for students and postdocs, and through external
scientific advisement. We will facilitate application of the advanced capabilities of new instruments in the NMR
facility and will expand the user base of a new EPR instrument. We also describe a sustainable business plan
for the core during Phase III and the period beyond COBRE funding. Continuing our past practice, we propose
to sustain the core through instrumentation proposals to update our equipment and scientific infrastructure. The
support of hard-funded core scientific staff across our core provides the human infrastructure required for
successful instrumentation proposals and the overall foundation needed for long-term sustainability of our center.

Public health relevance
PROJECT NARRATIVE A project narrative is not required in this component.